Maladaptive epigenetic control of MUC5B transcription in pulmonary fibrosis

Project Summary
In this project, we will define epigenetic and transcriptional mechanisms that result in increased MUC5B
expression, distal airway epithelial abnormalities, and associated fibroproliferative phenotypes. Idiopathic
pulmonary fibrosis (IPF) has a 5-year mortality rate surpassing many cancers. The G-to-T transversion,
rs35705950, is the most potent known risk factor for developing IPF and is located ~ 3 kb upstream of the
MUC5B gene. This -3 kb region regulates MUC5B expression, which is increased in IPF, especially in terminal
bronchiole-like regions. Bronchioles are a primary site of IPF pathogenesis and feature aberrant epithelial
differentiation in disease, promoting local recruitment and activation of fibroblasts. Although rs35705950 and
MUC5B are key players in IPF pathogenesis, rs35705950 alone is not sufficient to cause IPF, and we don’t
fully understand how MUC5B and rs35705950 promote IPF pathogenesis. Our proposal is based on a two- hit
hypothesis that addresses these gaps. We hypothesize that MUC5B overexpression, potentiated by epigenetic
changes, primes the bronchiolar epithelium such that a second injurious hit results in aberrant epigenetic
regulation, detrimental ER stress and fibroblast activation. Three Aims address this hypothesis. In Aim 1, we
will determine molecular control of MUC5B transcription in proximal and distal airway epithelia from unaffected
and IPF subjects. This work extends our preliminary data on -3 kb MUC5B enhancer function, and we will
specifically test whether the pioneer transcription factor, FOXA2, induces chromatin remodeling, enhancer
RNA transcription and MUC5B expression through methods such as ChIP and factor knockdown. In Aim 2 we
will identify epigenetic and transcription factor mechanisms that drive abnormal distal airway epithelial cell
differentiation in relationship to MUC5B expression and genotypes in IPF. Aim 2 is motivated by our data
implicating important roles in IPF for two transcription factors involved in normal airway epithelial differentiation,
EHF and GRHL2. Our methods in Aim 2 will include ATAC-seq, nascent transcript sequencing, knockdown
and ChIP to define mechanistic roles for these factors in IPF, with extension of our findings into human
samples and cells from Muc5b overexpressing mice. In Aim 3, we will investigate the role of airway epithelial
epigenetics and MUC5B expression on transcriptional control of ER stress and fibroblast activation in IPF. Aim
3 builds on our data supporting an epigenetic mechanism in detrimental ER stress responses where IPF-
derived cells direct the master ER stress regulator, XBP1(S) to interact with open chromatin at motifs for the
ATF family of transcription factors. We will extend on these findings through applying ATAC-seq and ChIP-seq
to study XBP1(S) genomic occupancy and ATF4 crosstalk in IPF-derived human airway epithelial cells. We will
also study fibroblast epigenetics in relationship to airway epithelial abnormalities in IPF. Taken together, these
studies will advance our molecular understanding of transcriptional control in IPF pathogenesis and identify
new targets for restoring distal airway epithelial function in this devastating disease.